Tumor-Selective Delivery Approaches for Medulloblastoma

The majority of primary brain tumors result in high morbidity and very poor survival. Brain tumors are
now unfortunately the leading cause of cancer-related death in children. Medulloblastoma is the most common
malignant pediatric brain tumor resulting in the death of nearly one-third of afflicted children despite very
aggressive therapies that include surgical resection, whole brain and spine radiation therapy, and systemic
chemotherapy. Furthermore, the vast majority of surviving children have poor outcomes and significant
neurocognitive deficits due to the toxicity of these therapies. A major barrier to improving outcomes for primary
brain tumor patients is the relative ineffective delivery of therapeutic agents across the blood-brain barrier
(BBB) specifically to brain tumor cells while sparing normal surrounding brain tissue.
Heretofore, researchers have found few mechanisms to target therapies specifically to primary brain
tumors, to avoid systemic toxicities. We seek to address this problem to improve drug therapeutic indices by
proposing a strategy to target therapies specifically to brain tumor vasculature utilizing a novel nanoparticle-
based drug delivery system that has high affinity to P-selectin on endothelial cells within tumors. Our
preliminary studies show selective nanoparticle extravasation and targeting to tumors across the blood-brain
barrier in a novel autochthonous GEM medulloblastoma model. Our team proposes a strategy to localize both
conventional and precision drugs to brain tumor tissue by targeting therapies to P-selectin on tumor
vasculature. We will employ a physiologically and genetically-relevant mouse model of Sonic hedgehog-driven
medulloblastoma to identify synergy with radiation therapy in enhancing tumor-selective nanoparticle drug
delivery, and will pursue the following specific aims: 1) To evaluate the P-selectin-mediated targeting, role of
radiation, and mechanism of extravasation across the blood-brain barrier in medulloblastoma, 2) To assess the
efficacy and toxicity of P-selectin-targeted chemotherapy/SHH pathway inhibition in Sonic hedgehog-driven
medulloblastoma, and 3) To assess the effects of focal radiation therapy of primary medulloblastoma tumors
on P-selectin and nanoparticle drug delivery to distant leptomeningeal brain tumor metastases within the
central nervous system in vivo. We will utilize biochemical and imaging methods including intravital multiphoton
microscopy, confocal immunofluorescence and immuno-EM, micro-CT for bone analysis, pharmacokinetic and
biodistribution measurements, and molecular biology approaches to assess nanoparticle delivery mechanisms,
treatment efficacy, and toxicity. Our primary endpoint is to identify tumor-selective strategies that synergize
with current standard of care therapies for medulloblastoma. Should our results prove favorable, we envision
clinical applicability to patients with medulloblastoma and other primary brain tumors as well as neurological
diseases that have been shown to have endothelial inflammation including multiple sclerosis and stroke.

Public health relevance
This work proposes a new therapeutic strategy to deliver conventional or molecularly targeted therapies across the blood-brain barrier specifically to primary brain tumors. Studies will focus on medulloblastoma, the most common pediatric brain tumor in children, with the goals that brain tumor-specific drug targeting will enhance efficacy and minimize systemic side effects. Should our results prove favorable, we envision applicability to other primary brain tumors commonly seen in children and in adults as well as potential utility in neurological diseases with evidence of neuroinflammation including multiple sclerosis and stroke.